ER stress-induced translational regulation in retinal degeneration

PROJECT SUMMARY
Autosomal Dominant Retinitis Pigmentosa (adRP) is a heritable retinal degeneration disorder that results in
progressive vision loss and subsequent blindness. Nearly a third of adRP patients possess a mutation in the
light-sensing G-protein coupled receptor, Rhodopsin. Many of these mutations cause the rhodopsin to misfold
in the Endoplasmic Reticulum (ER) resulting ER dysfunction that leads to retinal degeneration. The age-related
nature of the disease is likely because ER stress response pathways that protect against misfolded rhodopsins
decline with age. A better understanding of these pathways may therefore contribute to therapeutic strategy
development against adRP and other ER stress-mediated maladies. Here, I focus on one particular ER stress
response pathway that is initiated by a transmembrane kinase, PERK. Upon sensing misfolded proteins, PERK
phospho-inactivates a translation initiation factor, eIF2α, which inhibits protein synthesis and reduces ER
burden. Interestingly, these inhibitory conditions stimulate the translation of a transcription factor, ATF4, due to
its unusual 5'UTR. Our understanding of ATF4 induction is largely based on studies in yeast and remains
incomplete, thus it remains possible that there are as yet unidentified translation regulators that specifically
affect ATF4 translation but not canonical mRNA translation. In addition to translation regulation by phospho-
eIF2α, the PERK pathway engages a second translational inhibition mechanism via 4E-BP, which is a direct
transcriptional target of ATF4. With two translational inhibition mechanisms being activated by PERK signaling,
how are stress responsive transcripts (that are required to ameliorate ER stress) translated?
This proposal aims to address this major unanswered question regarding the PERK/ATF4 pathway by
employing a Drosophila model of adRP to determine the pathological consequence of ATF4 signaling wherein
mutant Rhodopsin-1 (Rh1G69D) imposes ER stress and leads to retinal degeneration. Preliminary studies were
conducted by screening RNAi lines targeting various translation initiation factors for loss of an ATF4 reporter
activity. This lead to the identification of a poorly characterized translational initiation factor as an unexpected
regulator of ATF4. Experiments in cultured mouse embryonic fibroblasts (MEFs) shows a phylogenetically
conserved role for this new factor in regulating ATF4 translation. Additional preliminary evidence indicates that
the newly identified factor regulates translation at the 5' UTR ATF4. Part of the experiments outlined in this
proposal is designed to determine how this factor regulates translation of ATF4 utilizing cutting-edge ribosome
profiling techniques. The remainder of the proposal details a strategy to understand the role of the second
translational inhibitor downstream of PERK, 4E-BP, in retinal degeneration. If realized, this project will
significantly further our understanding of translation control during retinal degeneration in addition to providing
valuable pharmaceutical targets for ER stress-mediated maladies.

Public health relevance
PROJECT NARRATIVE The goal of this project is to characterize the role of mRNA translation regulators in the etiology of autosomal dominant retinitis pigmentosa (adRP) using a Drosophila model. The regulators characterized herein are engaged by a stress response pathway, which is activated in several classes of adRP. Mechanistic understanding of such regulation will aid in the development of therapeutic strategies against adRP and other maladies that see the activation of this pathway, including age related macular degeneration, atherosclerosis, diabetes and neurodegenerative disorders.